Advanced MR Imaging of Early Osteoarthritis

Project Summary / Abstract
This is a renewal application for a Midcareer Investigator Award in Patient-Oriented Research (K24).
The applicant, Dr. Garry Gold, is a physician-scientist, Professor of Radiology, Bioengineering, and
Orthopedics at Stanford University. Over the past 15 years, Dr. Gold has developed expertise in several
advanced musculoskeletal imaging and biomechanics techniques and applied these to the study of
osteoarthritis and joint diseases. This has led to his developing an independent patient-oriented
research (POR) career. He has received two independent research awards from the NIH that use MR
techniques to investigate the pathophysiology of musculoskeletal diseases (both from NIBIB) and
recently received an award from NIAMS to use Weight-Bearing CT to study joint loading. Dr. Gold has a
10-year history of mentoring junior clinician scientists, postdoctoral fellows, medical students,
graduate students, and undergraduates - all performing POR. In addition, Dr. Gold has active
collaborations with many NIH-funded investigators in the area of musculoskeletal research and
imaging. The current application requests funding (50% salary) for 5 years. This funding will guarantee
that the candidate will have at least 70% protected time to conduct his ongoing research and to
continue to mentor clinician scientists performing POR. This award will free time now devoted to
administrative and clinical responsibilities to focus more on his research and mentoring activities over
the next 5 years. In addition to working on the ongoing NIH-funded projects, Dr. Gold will obtain
additional training in advanced MR collection and analysis methods. This will allow the candidate to
develop new approaches to apply to the imaging of musculoskeletal diseases. Given the outstanding
resources and collaborations at Stanford, these novel projects are expected to be either renewed or to
lead to new directions in orthopedic research, and significantly contribute to our scientific
understanding of these disabling conditions.

Public health relevance
Project Narrative Musculoskeletal diseases such as osteoarthritis have a tremendous impact on the individual and society as a whole. We need better imaging tools to detect these diseases at an early, treatable stage. This renewal of a K24 award will permit the PI to maintain his efforts in mentoring junior investigators in patient-oriented research, and to conduct research to improve detection, understanding, and treatment of patients with musculoskeletal disease.